Role of disrupted ASL pH regulation in small airways in CF lung disease pathogenesis

PROJECT SUMMARY / ABSTRACT
Cystic fibrosis (CF) is a common genetic disease caused by a defect in the CF transmembrane conductance
regulator (CFTR). The pathogenesis of CF lung disease is unclear and controversial, at least partially due to
lack of studies in an appropriate CF animal model. In addition, most studies regarding the pathogenesis rely on
data from cultured human diseased large proximal airways, such as tracheal and bronchial tissue. However,
pathological and clinical data suggest that the disease is initiated in small airways with a diameter <2mm.
Iowa group has engineered pigs with deletion or mutation of CFTR. These pigs mimic human CF, including
development of spontaneous infections and obstruction of airways with mucus and inflammatory cells. This
model provides an unprecedented opportunity to investigate the pathogenesis of CF lung disease. Our
objective for this study is to investigate how loss of CFTR leads to host defense defects in CF small airway
epithelia and if viral vector mediated delivery of CFTR cDNA to CF small airways will rescue host defense
defects. Our overall hypothesis is that AAV4 mediated delivery of CFTR will correct ASL properties and restore
host defense function of small airway epithelium in CF. In Aim 1, we will use AAV4 to deliver CFTR cDNA in
cultured small airway epithelial cells from CF pigs and examine ASL properties including pH and viscosity and
bacterial killing abilities. In Aim 2, we will use human small airway epithelia from CF patients to test the
hypothesis. In Aim 3, we will examine the cellular tropism and efficiency of AAV4 mediated gene delivery to
small airway epithelium in live pigs and human lung explant. The proposed studies will lead to a better
understanding of the CFTR-mediated host defense mechanisms and illustrate a potentially important yet
previously underappreciated role of small airway epithelial cells in pathogenesis of CF lung disease.

Public health relevance
PROJECT NARRATIVE / PUBLIC HEALTH RELEVANCE STATEMENT Cystic fibrosis (CF) is a common genetic disease caused by a defect in the membrane pore protein CFTR, and CF lung disease is the most common cause of death in CF patients. This proposal addresses how mutation of a membrane pore protein leads to infection and bacterial growth, and how these characteristic features of CF lung disease differ in the different regions of the lung. Defining regional differences in development of CF lung disease is essential to understand the disease's origins and to identify new therapeutic pathways for CF.